Integrating Generative AI with Biomechanics Modeling to Advance Ventricular Disease Diagnosis and Personalized Treatment

Abstract: Ventricular-related diseases, including hypertrophic cardiomyopathy, heart failure, and dilated
cardiomyopathy, significantly contribute to the global burden of cardiovascular disease (CVD), which claims
around 17.9 million lives annually. This underscores the urgent need for enhanced prevention, diagnosis, and
personalized treatment strategies. Personalized computer-based heart modeling offers a powerful, non-invasive
approach to understanding cardiac function by revealing complex structure-function relationships, are widely
used in cardiac research, disease analysis, device design, and treatment planning. Accurately predicting heart
behavior is challenging due to the difficulty in measuring cardiac tissue material properties and determining the
stress-free configuration from stressed myocardium in medical images. Current methods, such as finite element
analysis (FEA) for predicting biomechanical outputs and inverse FEA for identifying material properties, are
robust but often slow, limiting their clinical application and the advancement of personalized cardiovascular care.
This proposal aims to develop and validate an end-to-end generative AI framework that efficiently and accurately
predicts the biomechanical outputs (e.g., motion and stress) of the passively deforming bi-ventricular
myocardium while identifying material properties and determining the stress-free configuration using patients'
3D imaging data and clinical measurements. We hypothesize that generative AI models trained on this data
can serve as accelerated emulators for both forward and inverse FEA tasks, enhancing personalized
diagnosis and treatment of ventricular diseases. This 3-year project focuses on passive mechanics related
to the late-diastolic stage, using 3D heart imaging and clinical data from normal patients to train the generative
AI framework before extending it to incorporate various diseases. Aim 1 will develop a generative AI-based FEA
emulator to efficiently predict passive bi-ventricular biomechanical outputs, enabling faster patient-specific heart
function analysis. Aim 2 will create an end-to-end generative AI framework to determine stress-free
configurations and optimal material parameters from 3D imaging and clinical measurements, incorporating
uncertainty quantification for robust parameter estimation. Aim 3 will establish a fine-tuning mechanism to adapt
generative AI models for accurately predicting biomechanical outputs in diseased hearts, integrating patient-
specific disease characteristics. Besides, this project will enhance interdisciplinary student involvement in
medical research through hands-on learning and collaboration with top medical schools, fostering interest in
health-related careers. This project develops a framework for personalized heart modeling that enhances clinical
decision-making and has the potential to save lives. It innovatively integrates generative AI with biomechanical
modeling, using a single neural network to address both forward and inverse FEA problems for rapid predictions
that outperform traditional methods. Our close collaboration among experts in cardiovascular modeling, medical
imaging, and clinical care ensures project success.

Public health relevance
Narrative: While predictive computational modeling has shown great potential for addressing ventricular diseases, traditional finite-element-analysis-based methods are too slow for effective clinical use. This proposal aims to develop an end-to-end generative AI framework that efficiently predicts biomechanical outputs and identifies material properties from patients' 3D imaging data, enhancing personalized diagnosis and treatment of ventricular diseases. By integrating generative AI with biomechanical modeling, this project seeks to revolutionize heart modeling, improve clinical decision-making, and positively impact patient outcomes.